Rewiring of regulatory networks by endogenous retroviruses

Project summary
Endogenous retroviruses (ERVs) are ubiquitous genomic parasites originating from ancient infectious
retroviruses, and constitute 8% of the human genome. Large-­scale genomic studies have revealed ERVs as
major source of transcriptional regulatory elements in mammalian cells, suggestive of an extensive role in driving
the evolution of gene regulatory networks in both health and disease. However, the specific consequences and
biological significance of ERV regulatory activity remains controversial and not well understood. The proposed
research seeks to investigate emerging roles for ERVs in (1) the evolution of immune regulatory networks and
(2) gene dysregulation in cancer. First, we will investigate a potentially fundamental role for ERVs driving
regulatory evolution of innate immune responses in mammals, through genome-­wide epigenetic and
transcriptional profiling of the interferon response in cells derived from diverse mammalian species. This work is
positioned to uncover a recurrent role for ERVs in regulating immune pathways, which may reveal pervasive
underappreciated differences in immune responses across species. In a second line of research, we seek to
investigate how the epigenetic derepression of ERVs in cancer contributes to pathological gene expression. The
transcriptional reactivation of ERVs is a hallmark of many cancers, but their potential contribution to disease
remains poorly understood. We will investigate how reactivated ERVs might cause widespread regulatory
dysfunction as a global source of cancer-­specific promoters, enhancers, and noncoding RNAs. Focusing on
colorectal cancer as a model, we will repurpose pooled CRISPR screening to investigate how reactivated ERVs
regulate phenotypes contributing to oncogenesis. Our interdisciplinary approach synthesizes functional
genomics, genome engineering, evolution, and disease to form a comprehensive platform for deciphering the
consequences of ERVs on mammalian biology.

Public health relevance
Narrative Endogenous retroviruses are remnants of past retroviral infections and make up 8% of our genomes. There is growing evidence that the reactivation of these viral sequences plays an important role in many human diseases including cancer and autoimmunity. This proposal will integrate genomic analysis and immunological approaches to advance our understanding of how these elements impact cellular function in health and disease.